Structural transitions and RNA-mediated mechanisms of LSD1

Project Summary/Abstract
This project is centered on the hypothesis that RNA structure and RNA-chromatin associated protein
interactions play crucial roles in maintaining genome stability. It is known that non-coding RNAs (ncRNAs)
interact with protein components of chromatin, thus altering the higher order genetic architecture and gene
expression. A subset of these RNA-protein interactions are linked to ageing, cancer metastasis, and neuronal
development. As genomic approaches begin to identify RNA-protein associations and their links to cancer,
there remain key gaps in our knowledge regarding epigenetic-based RNA binding proteins. RNA can mimic
DNA, form transient DNA/RNA hybrids under cell stress, and function as scaffolds to recruit protein complexes
to chromatin. Further, these RNAs can interact with structured and disordered protein regions to form
multivalent networks that can undergo liquid-liquid phase separation, or biomolecular condensates. Thus,
examining RNA-protein assemblies in solution and in a condensed, clustered state akin to a compact cell
environment can address fundamental questions: 1) What are the sequence requirements or structural
features that drive formation of multivalent RNA-protein interactions? And 2) How do RNA-protein
conformational changes impact the function and activity of chromatin associated proteins? In this proposal, we
seek to understand how RNA interacts with the lysine specific demethylase-1 (LSD1) enzyme. LSD1 is an
essential methylation regulator and has oncogenic properties in many cancers due to its vast interaction
network and association with RNAs in cell differentiation and DNA damage response pathways. We will focus
on the telomeric repeat containing RNA (TERRA) that interacts with LSD1 in response to DNA damage at the
ends of chromosomes. These RNA-LSD1 interactions are involved in the regulation of heterochromatin at
telomeres. The co-I (Zhang) has discovered that telomere clustering occurs in telomerase-free cancer cells
and that this process is driven through RNA-mediated phase separation. We will use integrative structural and
cell biology approaches to demonstrate how specific nuclei acid structures engage with LSD1 and how larger
nucleic acids may serve as functional coregulators in telomere maintenance. We hypothesize that higher-order
RNA topologies function as crucial mediators of chromatin-associated proteins. The specific aims of this
proposal are thus 1) to define the structural mechanism and auto-regulatory role of an intrinsically disordered
region of LSD1, 2) to identify the mechanism of action for LSD1-RNA assemblies involved in telomere
maintenance, and 3) to determine the architecture and conformational rearrangements of a higher-order
TERRA in solution and in a biomolecular condensate state. The long-term goal of this project is to understand
how RNA structure and conformational dynamics influence LSD1-mediated regulatory networks. Results from
these studies will provide new mechanistic insight into RNA-based chromatin biology and serve as a starting
point in the development of therapeutics that target LSD1 and RNA in a context-specific manner.

Public health relevance
PHS relevance: Telomeres are tightly regulated to maintain chromosomal stability; misregulation of ribonucleic acid (RNA)- protein interactions at telomeres can lead to degenerative disorders and cancer. The goals of this study are to 1) understand how a telomeric structured RNA interacts with a chromatin associated protein and 2) define how these conformational transitions influence gene regulation. The results of this integrative structural and cell biology study will help in the development of therapeutics that target human disease and aberrant cellular differentiation.